Mechanism of TFEB-mediated proviral and antiviral autophagy during EV-D68 infection

Abstract
Enterovirus D68 (EV-D68) is a reemerging pathogen and a significant cause of acute
respiratory illness in infants. Recently, infection with EV-D68 has been associated with
severe respiratory disease and a neurological condition known as acute flaccid myelitis.
There is no prophylactic vaccine or specific antiviral to treat EV-D68 infection. Like other
enteroviruses, EV-D68 uses autophagic membranes for RNA replication and non-lytic
release. While autophagy is often proviral for EV-D68 and other enteroviruses, our
recent finding that the cellular process can also be antiviral by degrading the autophagic
membranes before the virus subverts them suggests that manipulating autophagy could
constitute a plausible antiviral strategy. We found that through a phenomenon called
Nuclear Evacuation of Autophagic Regulators (NEAR), transcription factor EB, the
master transcriptional regulator of autophagy and lysosomal biogenesis, controls
antiviral autophagy. Despite regulating antiviral autophagy, TFEB is also essential for
EV-D68 infection, since TFEB knockdown reduces EV-D68 titers. Interestingly, the viral
3C protease cleaves TFEB late during infection. These findings suggest that TFEB acts
as a double-edged sword during EV-D68 infection. Here, we propose three aims to
mechanistically characterize how TFEB regulates proviral and antiviral autophagy
during EV-D68 infection and identify the specific TFEB target proteins that
mediate these processes. We hypothesize that the TFEB target proteins
mediating antiviral autophagy will be distinct from those orchestrating proviral
autophagy. The objective of this proposal is to conduct experiments that will not only
enhance our understanding of viral manipulation of autophagy but also provide new
insights into the regulation of autophagy at the molecular level. With solid mentorship,
collaboration, and institutional support, the experiments outlined in this proposal will
help develop the necessary skills to transition into a successful independent
investigator.

Public health relevance
Project Narrative EV-D68 is a reemerging non-polio enterovirus and a significant course of acute respiratory infection in children, with the potential to cause severe neurological conditions known as AFM. For years, autophagy has been shown to promote EV-D68 infection. However, the same cellular process can be antiviral depending on the timing of induction. This project will clarify how TFEB regulates proviral and antiviral autophagy and inform the design of therapeutics against EV-D68.